Role of Gsx2 in hindbrain neurogenesis

Project Summary. Central apnea in newborns results from dysregulation of neuronal breathing circuitry. In
sudden infant death syndrome (SIDS), these circuits can function apparently normally at birth but fail at some
point in the first year. It is imperative to better understand the molecular and genetic requirements of developing
neuronal breathing circuitry to create neuronal targeted therapies for SIDS. Mice with homozygous null mutations
in the homeobox transcription factor (TF) gene Gsx2 die within hours of birth after becoming cyanotic and ceasing
to breathe. Our preliminary data demonstrate that Gsx2 is expressed in hindbrain neural progenitors of the “dA3”
domain which give rise to dorsal respiratory group (dRG) glutamatergic neurons in the nucleus tractus solitarius
(nTS) and their associated catecholaminergic neurons of the A1/C1 and A2/C2 groups. At birth, the Gsx2-null
mutants show a nearly complete loss of glutamatergic nTS neurons and A1/C1, A2/C2 catecholamine neurons,
consistent with their lack of viability. Furthermore, Gsx2 mutant dA3 progenitors exhibit a loss of the bHLH TF
Ascl1, despite that Ascl1 mutants only phenocopy the complete loss of A1/C1, A2/C2 neurons suggesting that
Gsx2 regulates other TFs for nTS neurogenesis. Functional analysis shows that Gsx2 null mice aspirate milk
when fed and display fewer apneas than their control littermates, consistent with the nTS regulating beneficial
apneas and gating between swallowing and breathing for airway protection. The central hypothesis for this
proposal is that Gsx2 directly regulates Ascl1 to induce differentiation of early-born A1/C1, A2/C2 catecholamine
neurons and glutamatergic nTS neurons, but additional direct target TF genes are required for the normal
generation of glutamatergic nTS neurons. To test this hypothesis, 2 aims are proposed. In Aim 1a, Gsx2 will be
knocked out during early (E9.5) and late (E11.5) dA3 nTS neurogenesis using a tamoxifen-inducible Olig3-
CreERT2 mouse and conditional Gsx2Flx allele to assess the neuronal alterations and effect on swallowing and
breathing. In Aim 1b, E10.5 dorsocaudal hindbrains containing Gsx2+ progenitors will be dissected, RNA-seq
performed on Gsx2-nulls, and CUT&RUN performed on Gsx2Flag/Flag animals to identify direct transcriptional
targets of Gsx2 in dA3 progenitors. In Aim 2a, Ascl1 will be conditionally re-expressed (with tetO-Ascl1) in the
Gsx2-null background, and in Aim 2b, Ascl1 will be conditionally knocked out (with Ascl1Flx) in dA3 progenitors
in both cases using Gsx2e-CIE to determine if Ascl1 is a) sufficient, and b) required for differentiation of dA3-
derived A1/C1, A2/C2 neurons in breathing, airway protection, and survival. Successful completion of these aims
will decipher the temporal requirements of Gsx2 in dA3-derived dRG neurogenesis as well as the gene regulatory
network (GRN) controlled by Gsx2 during hindbrain neurogenesis, contributing to our understanding of central
control of breathing. The training received at Cincinnati Children’s Medical Center under Drs. Kenneth Campbell
(neural development) and Steven Crone (breathing physiology) will help the applicant build a novel hindbrain
respiration control research program in the Campbell lab and transition into an independent investigator.

Public health relevance
Project Narrative The nucleus tractus solitarius (nTS) within the dorsal-caudal hindbrain is critical for normal breathing responses to hypoxia (low oxygen) or hypercapnia (high carbon dioxide) and, importantly, pathology in this brain nuclei has been implicated in sudden infant death syndrome (SIDS). The molecular genetic mechanisms that direct the development of functional chemosensory neurons within the nTS remain unclear, particularly with respect to the network of transcription factors (TFs) that underlie the differentiation process. With the goal to elucidate this in the hope of someday creating targeted therapies for newborn breathing disorders such as SIDS, this proposal aims to define the role of Gsx2, a homeodomain TF expressed in hindbrain neural progenitors that give rise to the nTS neurons which are indispensable for breathing and ultimately, survival.